Role of CCR2 in osteoarthritis

PROJECT ABSTRACT
Joint damage caused by trauma can proceed to post-traumatic osteoarthritis (PTOA). Published data from us
and literature demonstrated the importance of the CC-chemokine receptor 2 (CCR2) and its ligand CCL2 in OA.
CCL2 is the most abundant ligand in humans, and we reported that high serum CCL2 is associated with
radiographic knee OA onset at 5 year followups and correlates with cartilage damage following ACL
reconstruction. Animal studies showed that PTOA progression can be slowed by pharmacological CCR2
targeting or by early ccr2 gene deletion in chondrocytes or osteoblasts. We and others have reported a major
role for CCR2 in chronic and acute pain. Macrophages play a role in OA onset, progression and pain and CCL2
is a powerful chemoattractant for macrophages. However, it is unknown how macrophage infiltration correlates
to PTOA damage and how CCL2/CCR2 contributes to macrophage activation vs an inflammatory phenotype.
Therefore, in the efforts to identify PTOA treatments that can impact multiple tissue degeneration, inflammation,
and pain, targeting CCL2/CCR2 axis may represent an ideal choice. Muscles absorb the loads of articular joints
and muscle dysfunction may precede and expedite cartilage deterioration. Literature and our preliminary data in
PTOA showed a decreased expression of critical genes required in muscular excitation/contraction, followed by
loss of muscle strength. However, how muscle changes relate to PTOA is unclear. We hypothesize that, following
injury, the CCR2-mediated tissue damage (in cartilage, bone and synovium) and increased inflammation (in
joints as well as systemically) can be reduced by treatment with the RS antagonist, alleviating pain and improving
muscle strength. In order to develop therapeutic methods for efficient CCR2 targeting in PTOA, our proposal
will establish: 1) the molecular events leading to the tissue degeneration and macrophage activation induced by
CCR2 and how they correlate to pain and muscle damage; 2) the CCR2 contribution to macrophage polarization
vs an inflammatory phenotype (M1) at different disease stages; 3) the interconnection among joint structure,
muscle strength and pain; 4) two efficient drug delivery systems for tissue targeting, avoiding extended high-
dose exposure while protecting the drug from degradation. To accomplish these objectives, we will use an inter-
disciplinary combination of in-vivo studies in a rat PTOA model in the following aims: in Aim 1 we will determine
the therapeutic potential of intra-articular CCR2 targeting on joint degeneration, inflammation, muscle weakness,
and pain during PTOA using biodegradable microplates for sustained local release. In Aim 2 we will specifically
target activated macrophages systemically and assess their contribution of to PTOA and pain; moreover, we will
use activated macrophages to systemically deliver RS to inflamed tissues to determine its contribution to
macrophage activation and phenotype while improving joint structure, muscle strength and pain. We will also
determine CCR2 downstream pathway changes in joint and muscle tissues. Moreover, the results obtained in
this work could be extended to other instances of PTOA or chronic OA.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will provide new targets to advance therapies for the early treatment of injury-induced osteoarthritis (OA). Our study provides a novel perspective to study OA pathophysiology in which joints and muscles are both target tissues, and both contribute to the pain associated to this disease. We are proposing two novel drug delivery systems and two potential new therapeutic targets that could be beneficial to limit both joint and muscle damage involved in OA, as well as inflammation and pain, opening new critical insights to treatment.